Integrating deep learning, magnetic resonance imaging and genomics to study myocardial fibrosis

Project Summary/Abstract
Myocardial fibrosis is commonplace in the aging heart. Accelerated extracellular matrix remodeling and collagen
deposition, triggered by chronic myocardial tissue injury, are associated with pathologic myocardial fibrosis, and
contribute to the rising burden of cardiovascular disease. Although the initiating triggers for myocardial tissue
injury are disease-specific, they activate a highly consistent set of core pathways of fibrosis that lead to
accumulation of myofibroblasts and fibrotic tissue remodeling. Unraveling the mechanisms that contribute to
myocardial fibrosis will enable prevention of myocardial fibrosis progression and design of therapeutic
interventions that could have a wide-ranging impact on multiple cardiovascular diseases.
Cardiac magnetic resonance imaging (MRI) with T1 mapping is a non-invasive histologically validated
quantitative method for assessment of myocardial fibrosis. Genome-wide association analysis is a powerful
analytical approach that can identify biological pathways linked to cardiovascular traits. However, adequately
powered genome-wide association studies of myocardial fibrosis in humans require large sample sizes with
combined genomic, cardiac MRI and clinical outcome data, which to date have been elusive. The UK Biobank
(UKB) is a unique longitudinal prospective cohort comprising ~500,000 participants with comprehensive
phenotyping, imaging, and multiple genomic data types. Approximately 100,000 participants have contributed to
the UKB imaging study, offering paired cardiac MRI and whole genome sequence data, with 60,000 participants
undergoing repeat cardiac MRI during follow-up.
The current proposal aims to: (1) harness machine learning to measure, at an unprecedented scale in 100,000
individuals in the UKB, myocardial segment-specific fibrosis burden and tissue heterogeneity and examine the
clinical relevance of these measured traits by examining their association with cardiovascular, metabolic and
inflammatory diseases; (2) leverage whole genome sequence data to identify coding and non-coding genomic
loci associated with myocardial fibrosis for potential therapeutic targeting; and (3) examine clinical and genetic
factors that contribute to myocardial fibrosis progression in the subset with repeat cardiac MRI.
This work will benefit from the robust scientific and computational infrastructure at the Cardiovascular Medicine
Division at the Brigham and Women's Hospital and the Cardiovascular Disease Initiative (CVDI) at the Broad
Institute of Massachusetts Institute of Technology (MIT) and Harvard. Dr. Nauffal will be mentored by Dr. Patrick
T. Ellinor, the Director of the CVDI and an expert in defining the molecular basis of cardiac fibrosis using genetics.
By completing the research and training aims outlined in this proposal, Dr. Nauffal will acquire proficiency in deep
learning methods, human genetic discovery, fibrosis imaging and longitudinal data analysis. These skills are
critical to achieve his goal of becoming an independent R01-funded computational cardiovascular geneticist.

Public health relevance
Project Narrative Myocardial fibrosis is a common feature of multiple cardiovascular diseases and is a hallmark of cardiovascular aging. The emergence of large biorepositories, such as the UK Biobank, with cardiac magnetic resonance imaging (MRI) and whole genome sequence data in 100,000 participants, combined with the advent of machine learning tools capable of generating imaging-based phenotypes at scale, offers a unique opportunity to study myocardial fibrosis. This proposal leverages cardiac T1 mapping, a validated MRI tool for myocardial fibrosis quantification, to advance our understanding of the genetic and non-genetic factors influencing myocardial fibrosis, thus, enabling the development of prevention and therapeutic strategies aimed at mitigating myocardial fibrosis and its associated morbidity.